The Johns Hopkins Center for AIDS Research (JHU CFAR)

The mission of the CFAR is to catalyze, support, and sustain the continuation of innovative research to end the
HIV epidemic in the United States and globally; our vision is The End of AIDS Begins Here. For the past 9
years the CFAR has reinvigorated a sense of community and connectedness among investigators in the
School of Medicine, Bloomberg School of Public Health, School of Nursing, and other JHU divisions; built
thriving platforms through which interdisciplinary collaboration occurs; engaged new and early stage
investigators (ESI) in cutting-edge research activities; provided vitally needed developmental resources for
conducting pilot studies; and contributed to the recruitment or retention of 13 junior faculty members, notably 8
members of underrepresented populations. Developmental Awards for pilot studies, microgrants for small
projects, and supplements have been provided to 217 ESI and investigators new to HIV, resulting in $263
million in subsequent extramural funding. JHU-authored publications on HIV have increased by 80% since
2008, with a total of 1240 supported by the CFAR. Forty percent of all HIV grants from the NIH are now
awarded to ESIs and new investigators who received developmental support from this CFAR (compared to 7%
when CFAR began), and the overall HIV funding research base has grown by $19 million per year. Generous
institutional co-funding supports the Baltimore HIV Collaboratory to build stronger connections within the
community, involving numerous stakeholders including the Baltimore City Health Department and community
organizations. The Collaboratory is also worked expanding the pipeline of future HIV researchers through the
Baltimore HIV Scholars Program, Generation Tomorrow and Generation Tomorrow Health Disparities Scholars
pipeline programs emphasizing trainees from underrepresented populations. We established the Mid-Atlantic
CFAR Consortium (MACC) with the District of Columbia and Penn CFARs that supports research on HIV
prevention in all three cities and awards MACC Scholar Grants to ESIs from underrepresented populations.
Our specific aims are 1) To enhance the integration and productivity of HIV/AIDS research across JHU and
with partners in the community and around the world; 2) To provide mentoring, support, and pilot funding for
the next generation of HIV/AIDS researchers, and to increase the pipeline of new investigators from groups
underrepresented in medicine and health; 3) To support multidisciplinary HIV/AIDS research by providing
critical services to investigators through four service cores; and 4) to mobilize and coordinate capacity from
across JHU to combat the local HIV epidemic in the Baltimore and St. Petersburg areas through research
partnerships, training, results dissemination, and strengthening of community-based interventions. The CFAR
has 7 Cores and 2 Scientific Working Groups that provide services and support innovation in high-priority HIV
research. The CFAR will continue to have a galvanizing and transformative impact on HIV/AIDS research at
JHU and we are delighted to submit this renewal application.

Public health relevance
The goal of this application is to enhance the ability of the Johns Hopkins University Center for AIDS Research (CFAR) to nurture and support high-impact HIV research and researchers across a broad range of disciplines and specialties in the multiple divisions of this major research university. The CFAR will recruit, mentor and support new investigators, including members of underrepresented population groups, provide research support services, and leverage the capacity of Johns Hopkins to help end the HIV epidemic in Baltimore and nationally.